HSR&D Research Career Scientist Award

As a sociomedical scientist, health services researcher, and implementation scientist, I have 20+ years’
experience and have been consistently VA funded with over $13 million as PI or Co-PI to lead complex and
impactful research in: 1) geographic correlates of health/healthcare, 2) patient safety, and 3) complementary
and integrative health (CIH) therapy effectiveness and implementation. I use advanced methods such as multi-
level modeling, geospatial techniques, natural language processing, and pragmatic trials. My CIH research of
the past decade has solidified my national and international stature within and beyond VA. For example, the
NIH considers me one of the few people internationally at the intersection of implementation and CIH. CIH is
a key VA “Whole Health” component and part of many top VA priorities. My work is often used to inform
Congress and has substantially shaped VA healthcare nationally. As such, I was given the 2019 HSR&D Health
Services Impact award.
I currently am PI of two major research and evaluation initiatives totaling almost $9 million, one being a center
with 9 projects. These ten current studies and projects stem mostly from one of my five most important studies.
The resulting paper, “What Should Health Care Systems Consider When Implementing Complementary and
Integrative Health…” was the third most cited paper in 2019 in the leading CIH journal, Journal of Integrative
and Complementary Medicine (JICM). VA Office of Patient Centered Care’s (OPCC&CT, the VA Office guiding
CIH/Whole Health policy) frequently uses it when shaping policy, referring to it as their “implementation
bible”. My current “APPROACH” trial for which I am Co-PI (with Dr. Steve Zeliadt, VA Puget Sound), is an
HSR&D Merit for a six-year, $4.3 million pragmatic trial. This high-profile study includes nine Co-Is from four
VAs to longitudinally examine the effectiveness of CIH therapies among the largest-ever sample of CIH
recipients (5,600+) and is conducted in partnership with the OPCC&CT. The other nine projects stemming
from that key 2019 paper are part of the Complementary and Integrative Health Evaluation Center (CIHEC),
for which I am PI. CIHEC is a large-scale QUERI Partnered Evaluation Initiative co-funded by OPCC&CT for
six years (funded in 2017, renewed every two years for $3.5 million to-date). As CIHEC’s Director, I have
overseen 22 Co-Is and staff in nine VAs to conduct nine CIH projects. All are done in collaboration with
OPCC&CT to help guide their national strategy, support evidence-based CIH implementation, and respond to
Congress. Their papers and reports have been the subject of briefings to Congresspersons, Congressional
commissions, and VA leadership, and have been featured in ORD and HSR&D publications circulated to VACO.
I have published 35 peer-reviewed papers in the past 3 years, 60% as first or senior author and 77% in higher
quality journals, with an h-index of 29 and an i10-index of 51. My most important CIH-related paper is the
above 2019 paper and my most important patient safety paper is, “What Context Features Might be Important
Determinants of the Effectiveness of Patient Safety Practice Interventions?”. Published in the prestigious BMJ
Quality & Safety in 2011, it was Editor’s Choice, and has been cited 185 times. I am an Associate Editor and on
the editorial board for the leading CIH journal, JICM, and have served as Guest Editor Medical Care twice. In
the past three years, I have had 26 VA mentees and collaborated with 101 investigators, most from 10 VAs or
universities, and have given many invited national and local lectures to VA clinicians and national leadership
and external briefings to 8 Congresspersons or Congressional staffers. For the past three years, I served as the
Los Angeles (LA) HSR&D Associate Director (until 2021) and served on four LA VA committees, four local VA
postdoctoral programs, and 23 VA and non-VA service activities. At UCLA, I am Adjunct Professor in two
departments, Medicine, and Health Policy and Management. I am the VA Director of the UCLA Los Angeles
Area Health Services Research Training Program and am faculty mentor in a second UCLA program.

Public health relevance
This career award focuses on partnered research on complementary and integrative health (CIH) therapies to facilitate the provision of evidence-based non-pharmacological approaches to help Veterans with their pain, anxiety, depression, and suicidal ideation. The current and planned research portfolio expands her current lines of research on CIH therapies across the nation through rigorous scholarship and increased mentoring and dissemination. That is, the Research Career Scientist Award will enhance her current capacity to mentor and train early- stage and established VA investigators. It also will help enable her to investigate innovative areas related to CIH therapies, while fostering the spread of evidence-based CIH therapies and disseminating research findings to an even wider variety of VA constituents, including policy- makers and Veterans, all to improve the quality of care for Veterans and Veterans’ lives.